Drinking Patterns, Lifestyle Factors & Chronic Conditions in Asian Americans

Abstract The proposed study, Drinking Patterns, Lifestyle Factors and Chronic Conditions in Asian Americans, aims to improve understanding of the risk relationship between harmful drinking patterns and chronic health conditions—specifically, cardiovascular and cerebrovascular disease (CVD), the leading cause of death for Asian Americans, and three common conditions that increase CVD risk (diabetes, hypertension, and high cholesterol level). No U.S.-based study has examined the relationship between drinking and these conditions in Asian Americans. This is an important gap as CVD risk profiles differ between Asians and non-Asians, and there are indications that drinking may pose a greater risk for Asians than whites. In addition to addressing this key knowledge gap, we aim to examine the influences of alcohol metabolizing genes in the drinking-disease risk relationship, extending beyond the field's usual focus on genotype-related protective effects against heavy drinking and alcohol dependence. Further, we will investigate synergistic effects of drinking pattern and other lifestyle risk factors on disease risk in an effort to identify underexplored factors that influence the relationship between drinking and chronic disease. This study will draw upon a nationally-representative Asian American adult sample (Asian N=2,978) from the pooled National Epidemiologic Survey on Alcohol and Related Conditions (NESARC) II and III. Logistic regression and structural equation modeling, and latent class analyses will be conducted to address three specific aims. Aim 1 is to test the hypothesis that lifetime drinking patterns are predictive of CVD-related conditions for Asian Americans and for their ethnic subgroups, and that this relationship is moderated by alcoholic beverage type. Aim 2 is to examine the roles alcohol-metabolizing genes play in the risk relationship between drinking and CVD-related conditions in two pathways. We will test: 1) the mediational hypothesis that Asian ethnic groups with higher prevalence of ALDH2*2 and ADH1B*2 have lower CVD-related risk via reduced drinking; and 2) the moderational hypothesis that ethnic groups with higher prevalence of ALDH2*2 and ADH1B*2 have a higher CVD-related risk, given the same pattern of drinking. Aim 3 is to test whether clustered lifestyle risk factors (i.e., harmful patterns of drinking, smoking, overweight, and physical inactivity) synergistically increase risk for CVD-related conditions and whether this risk is further elevated for low-SES individuals. Study findings will be used to develop a larger study that will examine drinking, other lifestyle factors, and alcohol-metabolizing genes to more fully understand these risk relationships prospectively and with greater precision.

Public health relevance
Public Health Significance Findings from this study may have highly specific implications for alcohol-related health interventions. If we find ethnic groups with high prevalence of ALDH2*2 and AH1B*2 and harmful drinking patterns (likely Japanese and Koreans) at high risk of CVD-related conditions, they can be targeted for interventions. Further, a set of simple questions about an individual's history of facial flushing or other related symptoms due to drinking could become a powerful tool to identify individuals who may be at high risk. This may also have implications for other populations beyond Asian Americans, including Jewish whites who have high prevalence of ADH2*2 and African Americans in whom ADH1B*3 (with its alcohol metabolizing properties similar to ADH1B*2). Lastly, Aim 3 findings have the great potential to inform a multi-pronged intervention to reduce alcohol-related health risks by simultaneously addressing harmful drinking patterns and their clustering with lifestyle factors. Multi- behavior interventions have been found to be more impactful than single-behavior interventions.